CRCNS: Multiple Time Scale Memory Consolidation in Neural Networks

Detailed description of the proposed use of the animals, including species,
strains, ages, sex, and number to be used;
Dissociated, primary cultures will be prepared from the cortex of new born mice of either
sex (mus musculus, Postnatal day 0-1). These experiments will be performed using
pups obtained from Vglut1-IRES2-Cre strains mated with Floxopatch (Lou et al., 2016)
strains so that pyramidal cells will express channel rhodopsin CheRiff and voltage
indicator QuasR2. Up to 5 cultures can be grown, which can be used for 5 experiments.
Justification for the use of animals, choice of species, and numbers to be used;
Description of procedures for minimizing discomfort, distress, pain, and injury;
and Method of euthanasia and the reasons for its selection.
Transgenic mice (category C) will be used because the experiments rely on the
expression of CheRiff and QuasR2 for optical stimulation/recording. There are no
alternative species.
All experiments are terminal. Newborn mice will be cooled in ice prior to cervical
dislocation and excision of the brain for culture preparation. All procedures are in
accordance with guideleines of the NYU Animal Welfare Committee.
The estimated number of animals below ensure that we have a continuous supply of
cultures to perform experiments on a daily basis. Based on our experience in the past 3
years, each postnatal day 0-1 (P0-P1) mouse will generate at least 5 culture
preparations. A viable culture will have a have a high density of neurons that express
the Floxopatch construct, which varies from mouse to mouse. Thus, if one culture is not
viable, all cultures derived from that mouse are also unusable. The success rate is
approximately 50%. Because cultures can be made only form P0-1 day old mice and
because it is not possible to determine whether expression is sufficient until the day of
the experiment 2-3 weeks later, we will need to make 2 sets of cultures per week. Thus,
we will need to maintain 2 breeding pairs per week or 8 breeding pairs per month to
have a continuous supply of cultures. The breeding pairs will either consist of wildtype
mice (for viral injection) or Vglut1-IRES2-Cre - Gt(ROSA)26Sor (floxopatch) mice.
Breeding pairs will be replaced every six months.
Total animals for experiments: 32 mice/year (=16 mice (8 breeding pairs) x 2/year
replacement of breeding pairs).
To maintain the 3 lines, 2 males and 2 females each of Vglut1-IRES2-Cre,
Gt(ROSA)26Sor, and wildtype mice will be kept in separate cages (4+4+4=12 mice
total). Every 6 months (twice per year), the mice of each type will be bred. From their
offsprings, 4 males and 4 females from each line will be weaned and kept in separated
cages as above (4+ 4 + 4 = 12) and the 4 original breeding pairs (12 mice) euthanized.
Overall, 24 mice/year will be used to maintain the lines.
Total mice/year: 56 (=24 mice/year to maintain lines + 32 mice/year for experiment).
Total mice over 3 years = 168 mice.
Reference
Lou et al., (2016) Genetically Targeted All-Optical Electrophysiology with a Transgenic
Cre-Dependent Optopatch Mouse, J. Neurosci. 36:11059-73
1 53
Results from previous support from CRCNS
The P.I. and co-P.I. have not received previous CRCNS support
Coordination Plan
Division of labor The P.I. (A. Reyes) and his group at NYU will perform the experiments and analyses
detailed in Aims 1 and 2 of this proposal. The co-P.I (S. Fusi) and his group at Columbia University
will be responsible for the development of the theory and computational models that will incorporate the
experimental data.
Data Sharing between NYU and Columbia groups: Analyzed data, model codes, and manuscripts
in progress will be disseminated between the groups via Google drive. All members of the Fusi and Reyes
groups will have access upon email request. Larger, raw data will be stored on local servers and accessible
via FTP.
Coordination between NYU and Columbia University Because NYU and Columbia are easily acces-
sible by subway, we will have monthly joint lab meetings, alternating between NYU and Columbia. Graduate
students and postdoctoral fellows will be encouraged to submit joint poster presentations or talks to annual
meetings such as Cosyne and Society for Neuroscience Meetings.
16
54